INTRACRANIAL ANEURYSMS IN POLYCYSTIC DISEASE

This study is to determine the frequency & predictors of aneurysms in ADPKD Thus far, suggestive data suggest that aneurysms cluster in some ADPKD families.